Uncovering the role for MSI2 network in hematopoietic stem cells

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem cells (HSCs) must navigate important cellular fate choices that include a
symmetric self-renewal, symmetric commitment or undergo an asymmetric cell division where
one of the cells is fated to differentiate. Alterations in this homeostatic program can lead to
hematopoietic disorders and malignancies. Myelodysplastic syndromes (MDS) are a
heterogeneous set of clonal disorders characterized by ineffective blood cell development. A
common pathophysiologic mechanism in MDS is the presence of dysregulated hematopoietic
stem and progenitor cells that fail to normally develop into the diverse set of blood cells
necessary for normal function. Our laboratory and others identified MUSASHI2 (MSI2) as a
central regulator of HSC and hematopoietic progenitor cell self-renewal (Kharas et al. Nature
Medicine 2010). Additionally, we identified that Msi2 loss results in a defect in controlling
symmetric and asymmetric division, failure to engraft and results in defective maintenance of
myeloid lineage biased HSCs in part through control of the TGFβ pathway (Park et al. 2014
Journal of Experimental Medicine). We found that elevated levels of MSI2 expression predicts
poor outcome and using a genetic MDS mouse model that overexpresses MSI2 can drive a
more aggressive MDS (Taggart et al. 2016 Nature Communications). To determine if MSI2 is
part of a regulatory network, we performed proteomics and in vivo shRNA screen for functional
regulators of leukemia self-renewal. Based on this screen, we identified SYNCRIP, an RNA
binding protein that shares MSI2 targets and is required in leukemia stem cells (Vu et al., 2017
Nature Genetics). Our preliminary data with a conditional knockout for Syncrip indicates that it is
also critical for HSC self-renewal. Our proposal will expand our focus from MSI2 to its
associated regulatory network and characterize and identify new molecular determinants for
HSC and HSPC symmetric self-renewal and asymmetric fate choice. We have adapted new
technologies that include a barcoding, single cell RNA-seq and paired daughter HSC assays
(FATE-seq). We have also develop a new way to map direct mRNA targets in HSCs called
(HYPERTRIBE), (Nguyen et al. Nature Communications 2020).This proposal will identify new
regulators of HSPC fate choice which will lead to novel therapeutic strategies to improve
outcomes in MDS patients.

Public health relevance
PROJECT NARRATIVE Understanding how adult blood stem cells maintain themselves is essential for developing future cellular therapies and treating blood diseases including anemias, myelodysplastic disorders and hematopoietic malignancies. Previously, we found that the MUSASHI2 gene is essential for blood stem control and elevated abundance in patients with myelodysplastic syndromes results in a poor outcome. This proposal studies the mechanisms of the MUSASHI2 regulatory network for the development of novel future therapeutic strategies.